Identifying Disease-Specific Immune Cell Shifts in Chronic Fibrotic Interstitial Lung Diseases with Single-Cell RNA Sequencing

Project Summary/Abstract: Identifying Disease-Specific Immune Cell Shifts in Chronic Fibrotic Interstitial
Lung Diseases with Single-Cell RNA Sequencing
Description: Interstitial lung diseases (ILDs) are a heterogeneous group of lung disorders that cause scarring
of the lung parenchyma and affect an estimated 300,000 people in the United States alone. These diseases
can be categorized as having “intrinsic,” “extrinsic,” or “auto-immune” etiologies. A particular subset of chronic
fibrotic ILDs – idiopathic pulmonary fibrosis (intrinsic), chronic hypersensitivity pneumonitis (extrinsic), and
connective tissue-associated ILD (auto-immune) – can present with usual interstitial pneumonia (UIP) patterns
on imaging and have similar symptoms and pulmonary function tests. However, their prognoses and
treatments are distinct. Among them, idiopathic pulmonary fibrosis is associated with the highest mortality in
patients and confers a median survival time after diagnosis of three to five years. Moreover, incorrect diagnosis
and administration of immunosuppressive treatments to patients with idiopathic pulmonary fibrosis can
significantly worsen their disease. Therefore, it is critical to accurately diagnose these patients in a minimally
invasive manner, such as through peripheral blood draws. Obtaining peripheral blood mononuclear cells poses
little risk to patients and provides a window into their health; previous work by the application’s sponsor, Dr.
Naftali Kaminski, and his group demonstrated that PBMC cell-type composition and gene expression
signatures can distinguish idiopathic pulmonary fibrosis disease severity. Leveraging single-cell RNA-
sequencing (scRNA-seq) technology, we hope to elucidate the disease-specific immune mechanisms of ILDs
with UIP patterns (UIP ILDs) captured in the peripheral blood. In particular, Aim 1 will determine whether
disease-specific immune aberrations can be captured by peripheral blood cell-type composition and gene
expression signatures in idiopathic pulmonary fibrosis, chronic hypersensitivity pneumonitis, and connective
tissue disease-associated ILD. Aim 2 will ascertain whether there are distinct antigens that drive disease in
UIP ILD patients and will characterize the adaptive immune landscape in these diseases through B and T cell
receptor profiling. The goals of this study are three-fold: 1) to characterize disease-specific peripheral blood
biomarkers, 2) to create a clinical decision model that would diagnose a UIP ILD subtype given gene
expression, cell composition, T and B cell receptor repertoires, and patient clinical information, and 3) to gain
insight into UIP ILD disease mechanisms to advance patient therapeutics. In summary, the proposed research
will hopefully inform clinical diagnostics and treatments for patients with similarly presenting UIP ILDs. The
fellowship also includes a training plan with valuable learning experiences for the applicant’s development as a
physician-scientist.

Public health relevance
Project Narrative Accurate diagnosis of the subtype of interstitial lung disease (ILD) is critical for guiding both prognosis and therapy for patients. However, ILDs with usual interstitial pneumonia (UIP) patterns on imaging can be difficult to discern due to their similar symptoms, pulmonary function tests, and radiographic findings. This proposal will leverage the power of peripheral blood single-cell RNA-sequencing to determine immune cell aberrations that may drive specific ILDs with UIP patterns to advance diagnoses and therapeutics for these patients.